Administration

NCAN has three goals: to develop adaptive neurotechnologies; to translate them into important scientiﬁc and
clinical applications; and to train others in their principles and use and promote their wide dissemination. The
mission of the NCAN Administration is to manage NCAN personnel, budget, and activities so that these goals are
achieved efﬁciently and effectively. In accord with this mission, the Administration has four aims.
Aim 1 is to ensure that the three TR&Ds proceed smoothly. The administration: oversees project budgets and
personnel time commitments; establishes procedures for ordering equipment and supplies, monitoring delivery, and
obtaining replacements and repairs; manages interactions with the Institutional Animal Care and Use Committee
and the Institutional Review Board; monitors completion of required personnel training; and oversees travel
arrangements, publication processes, and intellectual property procedures.
Aim 2 is to accelerate translation of NCAN technologies to research and clinical use by ensuring that the
collaborative and service projects (CPs and SPs) proceed smoothly. For CPs, the administration: maintains
facilities, procedures, and schedules for regular NCAN-CP interactions; oversees hardware/software and data
transfers; ensures effective interactions with the other institutions; and supports formulation and submission of
joint publications. For SPs, the administration: establishes procedures for providing NCAN services; ensures
that questions from SP personnel are addressed quickly; and maintains records of SP achievements. The
administration also oversees the establishment of new CPs and SPs.
Aim 3 is to train others in using adaptive neurotechnologies and to promote their wide dissemination. The
administration: oversees assembly of training curricula and dissemination materials; schedules, publicizes, and
manages workshops and symposia; oversees arrangements for visiting scientists and students; recruits high-
school and undergraduate student interns for research experiences at NCAN; monitors maintenance of the NCAN
website to ensure that it is up-to-date and accessible; schedules and publicizes meetings and seminars; manages
interactions with the scientiﬁc and general media; leverages training/dissemination resources with commercial,
foundational, or governmental contributions; and manages budgets for workshops and symposia.
Aim 4 is to enable productive and efﬁcient participation of the External Advisory Committee (EAC) in deﬁning
NCAN objectives and procedures, evaluating outcomes, and making plans. The administration: schedules and
manages EAC meetings; assists the EAC in assembling its evaluations and recommendations; ensures that the
NCAN personnel respond promptly and appropriately to EAC input; keeps EAC members informed of NCAN
progress; and oversees recruitment of replacements for EAC members as their terms end.
In summary, the NCAN administration creates and maintains a working environment that enables NCAN personnel
to pursue and achieve their ambitious goals.